Molecular Basis of Immunity

Abstract
The immunologist of tomorrow must appreciate both basic and clinical immunology to effectively utilize modern
tools of research in the pursuit of new knowledge about immune mediated and infectious diseases and their
pathogenesis as well as for development of new vaccines and therapies against immune-mediated diseases.
Training the scientist and the physician-scientist in immunology and its relationship to infectious diseases as
well as to other related disciplines such as pathology, biochemistry, cell biology, and biotechnology will be
crucial for the future of immunological sciences. To facilitate the distribution of knowledge in the field of
immunology, the Immunology Training Program goals are to provide fundamental and research training to
4 predoctoral and 1 postdoctoral fellows with an immunology faculty of 25 preceptors including 7 new
faculty. The program is unique in that it encompasses faculty from the University of Oklahoma Health
Sciences Center (OUHSC) and the Oklahoma Medical Research Foundation (OMRF) as well as its strong
focus on microbial as well as host immunology. The participating training faculty are particularly strong
in the 4 disciplines emphasized in the Immunology Training Program, which include 1) Responses to
Pathogens, 2) Lymphocyte Development and Signaling, 3) Inflammation and 4) Autoimmunity. The faculty
preceptors have interacted on the OUHSC campus for years, forming a network that is particularly suited to
train a cohesive group of pre and postdoctoral fellows in molecular immunology. The program recruits
students and fellows from national and international sources, has strong NIH funded research programs, and
has new faculty and facilities all of which foster an atmosphere of excellence in training. The predoctoral
students are eligible for the training program after completion of their lab rotations and qualifying exam. The
Immunology Training Program will provide in-depth enrichment in the 4 sub-disciplines to the pre and
postdoctoral trainees. Postdoctoral fellows are strongly encouraged to take coursework and to mentor
predoctoral students to enhance their immunology experience. The Immunology Training Program advisory
and selection committee selects the pre and postdoctoral trainees and act in an advisory capacity. Since the
beginning of the program, September 1, 2001, the objectives of the program are being met to provide
excellence in research, and immunology course work as well as retreats and the Immunology Journal Club
class which has been important for teaching current state of the art immunology to the trainees and faculty.
Yearly retreats and the journal club class have been effective in bringing pre and postdoctoral fellows
together with the immunology training faculty in an environment that fosters excellence. Our program has
been and will continue to be important to prepare trainees for future careers in immunology.

Public health relevance
Project Narrative The Immunology Training Program in Oklahoma will recruit and train students pursuing a PhD and/or MD degree (predoctoral trainees) or individuals who already have the PhD and/or MD degree(postdoctoral trainees) to perform medical and basic research in immunology. For example, trainees might study how infections affect the immune system such as in the study of immune responses to vaccines or how infections may lead to autoimmune diseases or how the immune system develops or responds to infections. Training in research laboratories of nationally and internationally recognized scientists along with a curriculum in immunology classes, retreats and national meetings will provide crucial training for the future immunologists in the United States.